Core B - Developmental Core

Modified Project Summary/Abstract Section

PROJECT SUMMARY/ABSTRACT CORE B: DEVELOPMENTAL The mission of the Providence/Boston CFAR is to promote translational, clinical, behavioral, and basic research to reduce the incidence of HIV; address comorbidities, co-infections and complications; and develop the next generation of therapies and research for HIV cure towards Ending the HIV Epidemic (EHE). As the HIV epidemic evolves, the Developmental Core (Core B) is evolving in parallel in order to catalyze innovative scientific leadership. We focus our efforts on early stage investigators (ESI), trainee and faculty populations in the biomedical, clinical, behavioral and social sciences research enterprise, and senior investigators not yet involved in HIV work, so that they can become the leaders of the future. Our Specific Aims are as follows: 1.Aim 1. Provide short-term funding for HIV/AIDS specific research awards and mentoring for early career investigators (ESI) and investigators new to the HIV/AIDS research field. 2. Aim 2. Facilitate comprehensive mentoring for HIV/AIDS investigators at all stages of project development and implementation. 3. Aim 3. Provide state-of-the-art National Research Mentoring Network (NRMN) mentoring training to CFAR mentors. Core B will continue to provide essential support for both ESI and established investigators, including timely funding, creative mentoring, and valuable mentoring training. These efforts will include both the continuation of existing, effective programs, and the development of several innovations for the next cycle. First, we have developed a new type of domestic Developmental Grant focused on community-engaged research designed to lead to future EHE funding. We will implement this new developmental award type in year five of the current cycle, and continue it in the next cycle, with modifications as needed. Second, we will implement a new Grant Resubmission Award of up to $10K designed to help those whose NIH grants were favorably scored, but not yet funded. The goal of the award is to allow investigators to quickly and productively respond to reviewer’s comments. Third, to foster social and scientific connectedness among developmental award recipients, we will coordinate a series of meetings (6, 1-hour meetings/year) for awardees whose Developmental Grants are active. Since 2013, Core B has provided $1.99M of developmental funding which has produced $40.2M in subsequent NIH funding (ROI of 20:1), and in the last cycle we helped to attract 12 NIH supplemental awards worth $2.1M. Our existing programs and new innovations, we believe, will help Core B to continue to further the mission of the Providence/Boston CFAR.